Pain Management Collaboratory Coordinating Center (PMC3)

NIH-DOD-VA Pain Management Collaboratory Coordinating Center
Project Summary / Abstract Original
The Pain Management Collaboratory Coordinating Center (PMC3) will continue to (1) provide national
leadership and technical expertise in all aspects of research supporting the design and execution of high
impact Demonstration Projects that conduct cost-effective, large-scale, pragmatic clinical trials on non-
pharmacological approaches for pain management and other comorbid conditions in veteran or military health
care systems, and (2) make tools, best practices, and resources from these and other projects available to
facilitate research partnerships in VA and DOD health systems. The PMC3 will leverage the expertise of the
Pain Research, Informatics, Multimorbidities and Education (PRIME) Center of Innovation based at the VA
Connecticut Healthcare System (VACHS) and its partners at VACHS and Yale, including the VA Cooperative
Studies Program Coordinating Center/Clinical Epidemiology Research Center and the Yale Center for
Analytical Sciences and Section of Biomedical Informatics and Data Science, enhanced by a strong
partnership with colleagues at the Uniformed Services University for the Health Sciences Center for
Rehabilitation Sciences Research and a novel Military Treatment Facility Engagement Committee comprised
of collaborating DOD and university affiliated investigators devoted to facilitating successful pragmatic trials in
DOD settings. We will use our expertise in pain management, electronic health records (EHR), data systems
and the design and coordination of multi-site pragmatic trials to accomplish these objectives in collaboration
with our VA, DOD and Yale partners. To achieve these objectives, three specific aims will be addressed: Aim
1: To develop, adapt and adopt technical policy guidelines and best practices for the effective design and
conduct of pragmatic trials; Aim 2: To work collaboratively with and provide operational, technical, design and
other support to Demonstration Project teams to develop, initiate and implement a research protocol; and Aim
3:To widely disseminate NIH-DOD-VA Pain Management Collaboratory endorsed policies and best practices
and lessons learned within military and veteran health care systems. Achievement of these objectives and
Specific Aims promise to significantly accelerate the integration of evidence-based non-pharmacological
approaches for the management of pain into routine clinical care in Military and Veteran health care systems
consistent with key recommendations from the National Pain Strategy.

Public health relevance
PROJECT NARRATIVE The Pain Management Collaboratory Coordinating Center (PMC3) will continue to (1) provide national leadership and technical expertise in all aspects of research supporting the design and execution of high impact, large-scale, pragmatic clinical trials on nonpharmacological approaches for pain management and other comorbid conditions in veteran or military health care systems, and (2) make data, tools, best practices, and resources from these and other projects available to facilitate research partnerships in VA and DOD health systems. We will continue to use our expertise in pain management and the design and coordination of multi- site pragmatic clinical trials to accomplish these objectives in collaboration with our VA, DOD and Yale partners.